Riboswitch Dynamics at Atomic Resolution

Conformational dynamics play essential roles in the regulatory functions of coding and non-coding RNAs.
Many regulatory RNAs undergo these functionally important conformational dynamics as they are being
transcribed, a process referred to as ‘co-transcriptional folding’. While intrinsic RNA conformational dynamics
and co-transcriptional folding can be coupled to elicit biological functions, the underlying mechanisms remain
poorly understood due to difficulties in characterizing and examining RNA conformational dynamics in the
context of co-transcriptional folding. Towards our long-term goal of elucidating how regulatory RNAs function,
the overall objective of this proposal is to integrate breakthrough techniques of solution NMR, computational
modeling, and time-resolved chemical probing to uncover principles of regulation via co-transcriptional RNA
dynamics with specific applications to riboswitches, a class of non-coding RNAs that serve as ligand-
dependent gene regulators and are emerging targets for developing novel antibiotics. During the prior funding
period, we have challenged the conventional working model of riboswitches by showing that, under solution
conditions, the sensing aptamer domain of the fluoride riboswitch adopts the same conformation in the
presence or absence of the ligand. We found that the ligand-free sensing aptamer undergoes distinct
conformational dynamics involving a low-populated and short-lived excited state (ES), where the ES-
mediated conformational transition works in coordination with co-transcriptional folding to regulate ligand-
dependent transcription activation. The present proposal represents a continuum of our conceptual and
technological innovations towards understanding riboswitch functions, in which we aim to establish co-
transcriptional RNA dynamics based regulatory mechanisms, to advance new paradigms for transcriptional
and translational riboswitches, and to perform biochemical assays and mutagenesis to reengineer individual
regulatory steps to test predictions. To accomplish the overall objective, the proposed research details three
specific objectives that feature a gradual increase in the complexity: (1) characterize co-transcriptional RNA
dynamics of the transcriptional fluoride riboswitch, (2) characterize co-transcriptional RNA dynamics of the
translational fluoride riboswitch, and (3) characterize co-transcriptional RNA dynamics of the FMN
riboswitches. Results will be used to test the central hypothesis of this proposal that RNA structures have
evolved to encode distinct co-transcriptional conformational dynamics to facilitate regulatory structural
changes along specific functional pathways. By developing a deep mechanistic understanding of
transcriptional and translational riboswitches, the proposed studies will illuminate fundamental properties of
co-transcriptional RNA dynamics and its role in gene regulation. The conceptual framework and experimental
tools developed in the proposal can further assist the development of RNA-targeted antimicrobial
therapeutics and advance the molecular understanding of co-transcriptional regulation of functional RNAs.

Public health relevance
Public Health Relevance: Conformational dynamics plays a fundamental role in gene regulation by many regulatory non-coding RNAs, such as riboswitches that are widely found in bacteria, including some important pathogenic bacteria. The proposed structural, dynamic, and functional studies of co- transcriptional regulation of riboswitches will bring new insights into the molecular understanding of their regulatory mechanisms, hence providing basis for developing riboswitch-based regulatory tools for synthetic biology and riboswitch-targeted antimicrobial therapeutics.